Neutrophil Development During Inflammation and Atherosclerosis

PROJECT SUMMARY
Neutrophils acutely respond to inflammatory signals in tissues and play a role in cardiovascular disease
(CAD). After activation by cholesterol and oxidized low density lipoproteins, neutrophils produce cytokines,
degranulate to release myeloperoxidase, azurocidin, and elastase, generate neutrophil extracellular traps
(NETs), and trigger lytic cell death. Neutrophils are produced in the bone marrow by stem cell progenitors
and, once mature, egress to blood and tissues to fight inflammation. We recently discovered an early
committed neutrophil progenitor stem cell (NeP) present in human and mouse bone marrow. Here, we
present new data demonstrating the presence of NeP in the peripheral blood of mice and humans with
CAD, suggesting that NeP modulate granulopoiesis and inflammation outside of the bone marrow. In this
project, we will focus on inflammation via activation of the Nlrp3 inflammasome, as we find that Nlrp3 and
ll1b are highly expressed in NeP. Activation of the inflammasome sensor Nlrp3 triggers a robust
inflammatory response, including IL-1β production. In Project 1, we hypothesize that activation of the
Nlrp3 inflammasome within NeP triggers granulopoiesis and neutrophil heterogeneity which
promotes atherosclerosis progression. We will test our hypothesis by studying inflammasome
activation in both mice and humans with cardiovascular disease (CAD). In Specific Aim 1 we will test
how neutrophil subsets are phenotypically and functionally changed in human CAD patients
compared to healthy subjects. These subjects are undergoing medically necessary coronary
angiography as part of the ongoing Coronary Assessment in Virginia (CAVA) study, and their extent of
atherosclerosis is measured clinically. We will analyze NeP, neutrophil heterogeneity, and the role of the
neutrophilic Nlrp3 inflammasome in blood of these subjects and link these findings to clinical parameters.
In Specific Aim 2 we will use atherosclerotic mouse models to test how intrinsic action of the Nlrp3
inflammasome in neutrophils impacts granulopoiesis and atherosclerosis. We will use mixed
chimeric mouse models with Nlrp3-/-, Gsdmd-/-, and Gsdme-/- mice to assess how inflammasome pathways
in NeP regulate granulopoiesis. New neutrophil-specific and macrophage-specific Nlrp3 knock-out mice
crossed to atherosclerosis-susceptible, apolipoprotein E-deficient (apoE-/-) mice will be used to directly
compare how action of neutrophil vs macrophage Nlrp3 inflammasomes impact neutrophil heterogeneity
and atherosclerosis. We will use a new mouse model to assess Nlrp3 action in NeP versus mature
neutrophils on atherosclerosis. We will define how Nlrp3 inflammasome activation in neutrophil progenitors
impacts granulopoiesis and atherosclerosis, which in turn could lead to new therapeutic approaches
targeting Nlrp3 components in neutrophils for atherosclerosis and other inflammatory diseases.